Role of Platelet Bruton's Tyrosine Kinase (BTK) in Atherosclerosis

Project Summary
Atherosclerosis is the leading cause of cardiovascular disease, accounting for nearly 30% (859,125) of deaths
in the United States, with an estimated direct healthcare cost of $218.7 billion every year. Patients with late
stage atherosclerosis suffer from life-threatening complications, such as myocardial infarctions, ischemic
strokes, aneurysms, and multi-organ failure. Many current treatment options, such as anti-platelet and anti-
coagulant therapies, although successfully alleviating or preventing thrombotic events of atherosclerosis, carry
a risk for bleeding and hemorrhagic complications. Thus, there is a clear need to further understand the
molecular basis of hemostasis and thrombosis in order develop safer and more effective therapies.
In this regard, one recent therapeutic group of interest is tyrosine kinase inhibitors (TKIs). Tyrosine kinase
inhibitors targeting Bruton’s tyrosine kinase (BTK), including ibrutinib, have traditionally been used with great
success in treating hematological malignancies, such as chronic lymphocytic leukemia (CLL), and
inflammatory conditions, such as rheumatoid arthritis. Due to the central role of BTK also seen in platelet
activation, BTK inhibitors have recently been studied as a potential anti-platelet agent, demonstrating effects
against atherosclerotic plaque-triggered thrombus formation; however, the mechanisms by which platelet BTK
is activated and its functional effects remain largely ill-defined.
To this end, our proposal aims to characterize in platelets the regulation of BTK (Aim 1) and functional effects
of BTK (Aim 2) in atherosclerosis, to reduce thrombotic complications while minimally affecting hemostasis. To
investigate the role of platelet BTK in atherosclerosis, 1) we will bring together for the first time physiological
and phosphoproteomics methods to perform a combinatorial analysis delineating the regulatory signaling
cascades that activate BTK in platelets; and 2) we will define the effects of BTK activation on platelet functional
responses and investigate the interplay between platelets, endothelial cells, and leukocytes classically seen at
the microenvironment of atherosclerotic plaque rupture.
The potential translational relevance of our project will be the identification of safe and druggable molecular
target and mechanisms within the platelet activation pathway. Our research may ultimately provide rationale for
the development and use of classic BTK inhibitors as secondary anti-platelet and anti-thrombotic agents that
could safely benefit patients who suffer from atherosclerosis and its complications.

Public health relevance
Project Narrative Atherosclerosis is the leading cause of cardiovascular disease and death in the United States, where patients suffer from terminal thrombotic complications, including myocardial infarctions and ischemic strokes. New anti- platelet therapies, such as the BTK inhibitor ibrutinib, have shown great promise in recent years in treating thrombus formation in atherosclerosis, however the mechanisms behind their anti-thrombotic effects are still ill- defined. To this end, this proposal aims to characterize the role of BTK activity in platelets in inciting thrombotic events, potentially identifying BTK as a target for safe and effective treatment of atherosclerosis in patients.